IGF::OT::IGF NCCIH Study on Reproductive Toxicology Studies in Rats (POTS 16-000765)Period of Performance 07/27/2016 - 03/31/2018

The test agent is being considered for development as an anticancer therapeutic. The objective of this task was to characterize the target organ toxicities of an investigative agent that might move forward to clinical testing for anticancer activity. The information obtained from this investigation was used to identify drugs with the potential to treat cancer.